Early Life Stress Effects on Ventral Hippocampal Microcircuitry during Emotional Behaviors

I am a physician-scientist in psychiatry studying neural circuits involved in psychiatric illness using
animal models that enable us to record and manipulate real-time neuronal activity with single-cell resolution.
My career goal is to become an expert on developmental risk factors, microcircuit physiology, and emotional
processing. This career development award will support my work to determine the impact of early life stress on
ventral hippocampal microcircuitry and how this influences anxiety- and anhedonia-related behaviors in
adulthood. Early life stress (ELS) increases the risk of adult psychiatric illnesses, so understanding how ELS
affects the neural circuits controlling emotional behaviors would provide a mechanism for this increased
vulnerability and point towards therapeutic targets. We can model ELS in rodents by inducing fragmented
maternal care in the early postnatal period and then examine neural activity during anxiety-like and reward-
seeking behaviors in adulthood. The ventral portion of the hippocampus is directly connected to both fear and
reward circuits, and heavily involved in emotional processing. The balance between excitatory pyramidal cells
and inhibitory interneurons in the hippocampus is important for controlling the flow of information to and from
other regions of these circuits. ELS alters the development of interneurons and decreases excitatory and
inhibitory synaptic density in the hippocampus. We do not yet know how ELS affects hippocampal excitatory
and inhibitory cell activity in vivo and how these changes relate to observed behavioral differences. This
proposal will address these questions through three Specific Aims. In Aim 1, I will test the hypothesis that
altered anxiety-like behavior and decreased reward-seeking in adult mice after ELS are correlated with
increased pyramidal cell activity in the CA1 output region of the ventral hippocampus (vCA1). In Aim 2, I will
determine the effects of ELS on PV neurons in the vCA1 during development and adulthood. First, I will test
the hypothesis that ELS decreases vCA1 PV cell activity during anxiety-like and reward behaviors. Then, I will
test the hypothesis that precocious expression of PV in the hippocampus after ELS is associated with changes
in global hippocampal neural activity in response to positive and negative stimuli. In Aim 3, I will test the
hypothesis that inhibition of vCA1 PV cell activity in normally-reared adult mice can alter anxiety- and
anhedonia-like behaviors. I will conduct this work within the New York State Psychiatric Institute and Columbia
University under the mentorship of Drs. René Hen and Kevin Bath. The training objectives of this K08 are to
become an expert in in vivo calcium imaging and optogenetic manipulations in freely moving mice, animal
models for ELS and neurodevelopment, computational techniques for examining task-related representations
in neural firing, and volume microscopy imaging with immunostaining. Upon completing these scientific aims
and training objectives, I will be prepared to transition to the next phase of my career as an independent
investigator directing a research group at an academic medical center.

Public health relevance
PROJECT NARRATIVE Early life stress greatly increases the risk for developing psychiatric illness later in life. We seek to understand the mechanism of this increased risk by studying neural circuitry changes induced by early life stress during anxiety-related and reward-seeking behaviors. The long-term goal of this work is to improve our understanding of environmental risk factors for mental illness and find ways to reduce vulnerability in affected populations.